A Gut-Systemic Perspective for Metabolic Disease

ABSTRACT Support is requested for a Keystone Symposia conference entitled A Gut-Systemic Perspective for Metabolic Disease, organized by Drs. Tony K.T. Lam, Nancy A. Thornberry and Fredrik Bäckhed. The conference will be held in Santa Fe, New Mexico from March 22-26, 2019 Changes of the microbiome and nutrient sensing within the gut alter whole-body glucose and energy homeostasis. The underlying mechanism and the therapeutic potential of such metabolic regulation in diabetes, obesity, and related disorders remain largely unexplored. This Keystone Symposia conference aims to progressively highlight a spectrum of basic and translational investigations and discoveries that first focus on microbial-host interaction and nutrient sensing mechanisms. Other sessions focus on the interaction between the gut microbiome and nutrient sensing pathways as well as how these pathways could be targeted by small molecules and/or immunological responses within the gut to impact systemic organs and whole-body metabolic homeostasis. In summary, we anticipate this conference will foster interactions between the basic, translational, clinical and pharmaceutical researchers and promote collaborative work aimed at realizing the therapeutic potential of targeting the gut microbiota-nutrient sensing axis for the treatment of metabolic disorders.

Public health relevance
PROJECT NARRATIVE By assessing the contribution of gut microbiota and nutrient sensing to different metabolic diseases, research could lead to the development of new therapeutic approaches to improve human health. Innovative models allow researchers to better elaborate this link by investigating connections such as the gut-brain interaction as well as how small molecules and genetics affect the gut microbiota. This conference brings together a multidisciplinary audience to explore recent research that can be leveraged to develop novel tools to modulate the gut microbiota for human health.